Engineering Metal Ion-Immunity Crosstalk for Metalloimmunotherapy

Engineering Metal Ion-Immunity Crosstalk for Metalloimmunotherapy
Metal ions play essential roles in numerous immune processes through their unique structural,
catalytic, and regulatory interactions with immune sensors, ion transporters, enzymes, and
signaling pathways. Emerging studies have demonstrated that metal ions could modulate various
immune processes for disease treatment. This lays the foundation for a new class of
immunotherapy, which we dubbed “metalloimmunotherapy”. However, a comprehensive
understanding of metal ion-immunity crosstalk and effective strategies for delivering metal ions to
immune cells in vivo is still lacking in this field. The overarching goal of my lab is to understand
how metal ions interact with immune system and to leverage advanced medicinal strategies to
deliver metal ions to immune cells, modulating the immune system towards immunostimulatory
or anti-inflammatory states for disease therapy. In this proposal, we aim to address the key
knowledge gaps and technical challenges by systematically interrogating the metal ion-immunity
interactions and developing specialized metal ion delivery systems to activate or regulate immune
responses.
In Part I, we identified extensive modulatory effects of metal ions on various immune pathways
through a systematic high-throughput screening. Next, we will use gut as a window to investigate
such metal ion-immunity crosstalk in vivo and validate our findings. This will elucidate the specific
roles of metal ions in regulating gut immune cell functions and determine how these interactions
contribute to gut diseases, including colon cancer and inflammatory bowel diseases (IBDs).
In Part II, we proposed to engineer metal ion-immunity crosstalk to activate immune system for
effective treatment of advanced colon cancer. We will develop novel coordination nanoparticles and
hydrogels for effective delivery of metal ions and immune activators to amplify anti-tumor immune
response. We will further establish the mechanism of action and improve the efficiency based on
rational design.
In Part III, we proposed to engineer metal ion-immunity crosstalk to regulate immune system in gut
for treating IBDs. We will introduce two coordination nanoparticle-based strategies to target
pathogenic immune cells in gut, inhibiting multiple IBD-related inflammatory processes and restoring
immune balance.
Successful completion of the proposed studies will provide groundbreaking insights of metal ion-
immunity crosstalk and lay out a new framework for advancing metalloimmunotherapy. We will
uncover previously unknown metal ion-immune interactions and their roles in health and disease.
Furthermore, we will address key delivery challenges and biological gaps, paving the way for
breakthrough treatments for advanced cancers and severe inflammatory or autoimmune diseases.

Public health relevance
This research is relevant to public health because it aims to uncover how metal ions interact with the immune system and develop innovative strategies to harness these interactions for immune modulation. By advancing our understanding of metal ion- immunity interactions and creating new delivery systems, this work has the potential to lead to novel therapies for treating various immunological diseases, such as cancers and inflammatory colon diseases.